Administrative Core: Interventions to improve alcohol-related comorbidities along the gut-brain axis in persons with HIV infection

The Administrative Core is an essential component of the P01 application. The Administrative Core will maintain a central leadership structure and support core resources for the two Research Component projects proposed in this P01. The Administrative Core will provide a research infrastructure that help to ensure harmonization of measures across the two projects, so that data can be combined for future analyses led by the P01 Data Science Core. The Administrative Core will help to connect the new P01 research activity with existing infrastructure that our team has developed over the past decade as part of Southern HIV Alcohol Research Consortium (SHARC). The Specific Aims of the Administrative Core are to: (1) Provide centralized leadership and strategic planning. (2) Provide administrative and clinical research support related to recruitment, data collection, safety monitoring, quality control, and biorepository storage. (3) Integrate our research with our ongoing training, development, and community engagement activities. The Administrative Core will support a P01 Leadership Committee, co-chaired by MPIs Drs Cook and Cohen, that will receive input from a Program Advisory Committee and a Community Advisory Board. The Administrative Core will provide shared support for general research administration, regulatory monitoring, and recruitment/data collection. The Administrative Core will also ensure staff training, clinical research monitoring, and biorepository storage. Core services will support an an ongoing research recruitment team based at the University of Miami (UM) that is integrated with several research support organizations at UM including the UM Center for AIDS Research (CFAR). The Administrative Core will connect our P01 research with our existing T32 training program and other training activities, with the community engagement activities of the SHARC, and with other national HIV-alcohol consortia and P01-related activities supported by NIAAA. Overall, the Administrative Core will help to ensure that the research conducted within this P01 is integrated and connected to other alcohol-HIV research teams nationally and internationally, that we develop a diverse research workforce via connection to our training programs and research collaborative network, and that we maintain partnerships with healthcare providers and the community

Public health relevance
This P01 project has public health significance, because brain and cognitive dysfunction are among the most important health issues encountered by persons living with HIV as they age. Our P01 will evaluate three promising interventions that may improve cognitive functioning among persons with HIV who consume alcohol.